DREAMS - Enrichment Program

Diabetes mellitus is a significant health burden in the U.S. Focusing on the northern California and its Central Valley region, the DREAMS-CDTR will conduct clinical research and interventions designed to inform practice and policy change at the health system, community and policy levels. The DREAMS-CDTR activities include: an Administrative Core, Pilot and Feasibility Program, Enrichment Program, and three coordinated research cores - Health Engagement & Action Translational (HEAT) core, Methods and Data Integration (MDI) translational core, and National Diabetes Policy Research Resource core. The Enrichment Program will provide structure to the professional development and networking opportunities across the DREAMS-CDTR and the CDTR national network.